Tissue regulation of T cell function - Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
Our ability to manipulate immune function in inflamed tissues is currently limited by a lack of fundamental
knowledge of how cells function in an inflammatory milieu. Current approaches to mitigate tissue inflammation
focus on general immunosuppression or general blockade of leukocyte trafficking into tissues. In principle,
these strategies prevent disease but complications due to increased infectious disease have quashed
enthusiasm. Therefore, therapies need to become more inflammation-specific, be that by preventing
recruitment of specific types of T cells (blocking T cells for an allergic response but leaving influx of leukocytes
for bacterial clearance in the same tissue intact) or by blocking signals for specific cytokine production. This
Program seeks to identify context-dependent events that are critical for immune function in specific
inflammatory settings. To achieve this goal, the Program has developed innovative tools for intra-vital imaging
of inflamed tissue. The major objective of Core A is to provide administrative and scientific oversight to the
individual projects and Cores. Its scientific mission is to promote and create forums for scientific exchange
within the Projects, between groups at the Institution and the broader international scientific community.
Administratively, monthly meetings will be scheduled between Dr Fowell and the administrative staff to ensure
good communication and safety compliance and monthly meetings will be organized with project leaders and
the accountant to discuss individual accounts. To promote scientific exchange, monthly research-in-progress
meetings will be held to discuss conceptual and technical advances in individual projects that may impact the
Program as a whole. An annual “Immune Imaging” symposium will be organized from within this Core and has
been the highlight of the previous funding cycle with 4 Symposia held attracting leaders in the field as speakers
and a strong local and national attendance. We see this Symposium as a way to nucleate scientist across the
country to discuss challenges in the field and to exchange ideas on innovative technology that will facilitate the
in situ study of immunity, infectious or autoimmune, in inflamed tissues.